Regulating axon guidance through local translation at adhesions

PROJECT SUMMARY
This Research Supplement to Promote Diversity in Health-Related Research (PA-21-071) is to
support Jordan Headen to pursue predoctoral training in my laboratory. This proposal is a
supplement to my currently funded NIH R01 award (NS125146). In the proposal, we provide a
summary of the original (parent) R01, a research plan for the candidate, a career development
plan for the candidate, and the PI’s qualifications to mentor the candidate. Ms. Headen
completed her Bachelor of Science degree in Biology at Ball State University. During her
undergraduate, she worked in the Neuroscience laboratory of Dr. Ashley Kalinski, examining
molecular mechanisms contributing to neuroinflammation after nerve injury. As an
undergraduate, Ms. Headen published one co-authored publication. Ms. Headen’s long-term
career plans are to become an independent faculty member in academia with a research focus
on neuroscience. This supplement will provide Ms. Headen with extensive research experience
in molecular and cellular neurobiology, focusing on mechanisms underlying local translation
during axon guidance. Furthermore, this supplement will provide Ms. Headen with focused
career development training. Overall, this supplement will provide the training needed to submit
a strong F31 application at the beginning of her third year in the Ph.D. program and help her
achieve her goal of becoming a neuroscience professor in academia.

Public health relevance
PROJECT NARRATIVE This Research Supplement to Promote Diversity in Health-Related Research (PA-21-071) is a supplement to my currently funded NIH R01 award (NS125146) and will support Jordan Headen while completing predoctoral training in my laboratory. This supplement will provide Ms. Headen with extensive research experience in molecular and cellular neurobiology and focused career development training. This training will help Ms. Headen achieve her long-term career goal of becoming an independent faculty member in academia with a research focus on neuroscience in health and disease.